Structure and function of phospholipids and inositol phosphates in the nucleus.

Summary: Phospholipids and inositol phosphates are two classes of small molecules with well-known
functions in the cytoplasm, but poorly defined roles in the nucleus. The goal of my diverse group is to
understand the structural biology and functional genomics of these two classes of small molecules. We also
take chemical biology approaches to develop new small molecules to interrogate nuclear functions, which
informs therapeutic development for several human diseases. Nuclear lipids are enigmatic molecules because
they are found outside membranes, within the nucleoplasm and have metabolic and signaling properties
distinct from membrane lipids. However, we do not understand fundamental aspects of the structure or function
of nuclear lipids, which are ubiquitous, well conserved signaling molecules. Funding over the past 3.5 years
has used the NR5A nuclear phospholipid receptors as models to address these questions. Those studies
informed new approaches to small molecule screening for full-length NR5A2, the results of those screens
revealed new molecules that regulate these receptors in new ways, which we build on here. Over the next five
years, our studies will reveal the structures of ceramide, sphingomyelin and sphingolipid bound NR5A
receptors, as well as new small molecules and genes that regulate nuclear lipid signaling through NR5As,
enabling further progress. Nuclear inositol phosphates are soluble signaling molecules made by the nuclear
kinase “inositol polyphosphate multikinase”, or IPMK. Work from several groups has established IPMK kinase
activity regulates gene expression, however specific cellular mechanisms have remained unclear. Funding
over the past 3.5 years used genetics in human cells to show IPMK-generated inositol phosphates specifically
activate HDAC3 to regulate histone acetylation, further progress has been hampered by limitations inherent to
these genetic knockout/complementation approaches. To overcome this, we helped develop the first selective
chemical inhibitors of IPMK, which have revealed novel aspects of inositol phosphate signaling. Over the next
five years, we can now use these inhibitors to ask questions not previously possible, defining how IPMK
regulates transcription. Our group is uniquely positioned to address these diverse problems because we focus
on two model systems: the NR5A nuclear phospholipid receptors and IPMK. We have developed novel
chemical and genetic tools that give us unique ability to interrogate these difficult questions. Our work will
reveal how phospholipids and inositol phosphates control gene expression, with potential to impact cancer,
diabetes and the metabolic side effects of anti-psychotic drugs.

Public health relevance
Narrative: Phospholipids and inositol phosphates are two classes of small molecules with well-known functions in the cytoplasm, but poorly defined roles in the nucleus. The goal of my diverse group is to understand the structural biology and functional genomics of these two classes of small molecules, and develop new small molecules to interrogate nuclear lipid functions. Together, our lab is interested in the structural biology and functional genomics controlled by nuclear phospholipids and inositol phosphates, as well as the phospholipid metabolic enzymes that generate these important signaling molecules.